Nebraska Center for the Prevention of Obesity Diseases through Dietary Molecules

RESEARCH PLAN: PROJECT SUMMARY
GOAL OF THE PARENT AWARD. This administrative supplement is submitted by the Nebraska Center for the
Prevention of Obesity Diseases Through Dietary Molecules (NPOD), currently in Phase 2 COBRE funding at the
University of Nebraska-Lincoln (UNL). NPOD's mission is to prevent, treat, and cure obesity and co-morbidities
by harnessing the power of bioactive food compounds to ameliorate the adverse health effects of obesity. NPOD
Phase 2 is guided by four specific aims: 1) Increase NPOD's critical mass of researchers by hiring five early
career investigators, recruiting new early stage and senior investigators using pilot and seed grant funding, and
continuing to develop strategic alliances with complementary programs; 2) acquire additional equipment for the
research core and formalize experimental design services offered through the administrative core; 3) enhance
the center's mentoring structure and collaborative, multidisciplinary environment; and 4) implement hiring and
recruitment approaches to expand integration of fundamental nutrition and obesity research with clinical,
translational, and community research.
RESEARCH QUESTION FOR THE SUPPLEMENT AWARD. The proposed research will explore whether the selection
of genomic variants in gut bacteria by milk extracellular vesicles (MEVs) alters energy homeostasis in
infants. We have pioneered a novel line of discovery by demonstrating that small extracellular vesicles (sEVs)
and their regulatory cargo do not originate exclusively in endogenous synthesis but may also be absorbed from
milk (milk sEVs, MEVs). Human milk is a rich source of MEVs, and breastfed infants consume approximately
176 trillion MEVs per day. In contrast, formula is essentially free of MEVs and 90% of MEVs are degraded in milk
that was frozen in milk banks or at home due to ice crystal formation. The oral bioavailability of MEVs is
approximately 50% and the portion of MEVs that escapes absorption interacts with the gut microbiome. MEVs
do not only alter bacterial communities, but they also select genomic variants in bacteria where the variants are
transcribed into mRNA and clustered in pathways of energy metabolism (purines, glucose). Other studies are
consistent with these observations and reveal an up to 120-fold increase in purine metabolites in formula-fed
infants and an up to 12.5-fold increase in glucose metabolites in bacteria cultured in media containing a
nutritionally relevant concentration of MEVs compared to MEV-free cultures.
Motivated by these discoveries, we hypothesize that the dietary intake of MEVs alters energy homeostasis in
infants. We will leverage our complementary expertise in bacterial evolution, advanced computational biology,
and the development of innovative “energy sensor” mice to complete three specific aims. In Aim 1, we will assess
the selection of genomic variants in MEV-defined cultures of infant feces. Specifically, we will assess the selection
of genomic variants by MEVs using metagenomics analysis, their transcription using RNA-sequencing analysis,
and the effects on pathways implicated in energy homeostasis using metabolomics analysis. In Aim 2, we will
assess the effect of MEV selection on a host-adapted infant gut symbiont (Bifidobacterium infantis) in infants.
Specifically, we will leverage existing fecal metagenomic data to characterize how MEVs select genetic variants
in a host-adapted infant gut symbiont by comparing variants from infants fed frozen pasteurized milk or fresh
milk and test the effects of these variants on enteric inflammatory responses. In Aim 3, we will develop NAD(H),
NADPH, and ATP sensor mice in collaboration with the University of Arkansas for Medical Sciences' Genetic
Models Core and assess if MEV-defined diet consumption alters energy homeostasis in neonate mice.
HOW THIS PROJECT BENEFITS FROM A TEAM SCIENCE APPROACH. This research will benefit the IDeA community
by supporting three project leaders and four research cores across Nebraska, Nevada, and Arkansas, and two
veteran scientist consultants in Kansas and Nevada. A team science approach is essential to project success
because the combined expertise required is not currently co-located in one of the participating IDeA states. Only
together do we have the necessary expertise and instrumentation to conduct the proposed research. Our team
comprises Drs. Qiuming Yao (UNL; NPOD project leader in Phase 2), Steven Frese (University of Nevada, Reno;
not supported by NPOD), Jingjie Hao (director of NPOD's Biomedical and Obesity Research Core (BORC)), and
leverages the Genomics Core Facility and Mass Spectrometry and Proteomics Core Facilities at the University
of Nebraska Medical Center, the Genetic Models Core at the University of Arkansas for Medical Sciences, and
UNL's BORC. The parent COBRE grant's principal investigator (PI), Dr. Janos Zempleni, will contribute expertise
in milk extracellular vesicles and share archived samples.
Ultimately, this project promises to benefit the six million infants annually who consume formula and frozen milk
in the United State, e.g., recommending new milk storage protocols that preserve MEVs through economically
and technologically feasible approaches that will not raise regulatory agency concerns. This research aligns with
NPOD's mission, and we have identified a path to future funding from NIDDK and NCHID (NOT-DK-19-007).
NPOD's administrative core will support the team through reciprocal visits by project leaders and an in-person
workshop prior to project initiation attended by PI, project leaders and their staff, consultants, and two speakers.

Public health relevance
PROJECT NARRATIVE Obesity and its co-morbidities are major threats to the health of the U.S. public, and the 20% prevalence in children and adolescents is alarming (15 million children and adolescents). This administrative supplement draws expertise from four NIH IDeA states to decrease the prevalence of childhood obesity using a new technologically and economically feasible approach that involves preservation of extracellular vesicles in milk that is frozen for storage.